Chromatin Barriers Impacting Liver Development and Regeneration

Summary
The goal of this proposal is to investigate how changes in transcription factor and heterochromatin states
in embryos and the adult liver impact hepatocyte development, homeostasis, and regeneration. To do so we will
use new in vivo imaging technologies and genetic perturbations of heterochromatin to elucidate the molecular
interactions that drive cell fate specification. Previous work from the Zaret and Mir laboratories have revealed
that the interplay between transcription factor kinetics and heterochromatin limits cell plasticity in model systems.
We will use our new approaches to understand how ventral-lateral and -medial domains of the embryonic
endoderm induce hepatic fates and the morphologic transitions that form the liver bud. We will similarly
investigate, in wild type and heterochromatin mutant adult livers, how differential heterochromatin states and
transcription factor kinetics in the periportal, midlobular, and pericentral liver zones impact homeostasis and
regenerative responses. Although single-cell genomics have revealed heterogeneity of embryonic hepatocytes
and of cells in each zone of the adult liver, the functional significance is unclear. We propose that quantifying
regulatory protein and chromatin kinetics within living wild type and heterochromatin mutant embryos and adult
liver will provide novel insight into the basis for two origins of the liver and the functional nature of zonal
heterogeneity. The Zaret lab showed that heterochromatin promotes liver cell stability in mouse development
and identified diverse heterochromatin proteins that repress liver genes in adult cells. Using single-molecule
tracking in cultured liver cells they showed that the pioneer factors FOXA1/FOXA2 scan heterochromatin,
whereas the liver differentiation factor HNF4 is restricted to open chromatin. The Mir lab engineered high-
resolution light-sheet technologies to image transcription factor and chromatin kinetics within specific nuclear
domains in live Drosophila and pre-implantation mouse embryos. Mir discovered how transient high-
concentration hubs of transcription factors at target genes regulate zygotic gene expression in fly embryos. We
will couple our laboratories’ expertise, as seen by our preliminary data showing that liver regulatory proteins and
chromatin can be genetically perturbed and imaged at high resolution in live developing mouse embryos and in
adult liver slices. We ask in Aim 1: How do changes in heterochromatin, and the molecular kinetics and sub-
nuclear clustering of transcription factors and chromatin components that interact with it, dictate how fields of
endoderm cells acquire liver fates? Aim 2: How do protein kinetics and heterochromatic features impart different
homeostatic capacities in the three zones of the adult liver lobule and the abilities of the periportal and pericentral
zones to respond to liver damage? By bringing together state-of-the-art live imaging of embryos and liver slices
with genetic perturbation, we will reveal how heterochromatin states and chromatin and transcription factor
kinetics impact development in two domains of endoderm, liver homeostasis, and regeneration. The work will
inform new ways to make hepatic cells from pluripotent cells and paradigms for other gut-derived tissues.

Public health relevance
Project Narrative: Most studies of gene networks in liver have focused on how genes are activated, with little attention to how gene repression, most commonly through heterochromatin, contributes to liver induction and function. By perturbing liver-inductive signaling and heterochromatin, we will use small-scale genomics tools and state-of- the-art imaging of living embryos and liver slices to reveal how heterochromatin states and transcription factor kinetics impact the emergence of liver from two domains of embryonic endoderm and homeostasis and regeneration across different domains of the adult liver lobule. The work will inform new ways to make hepatic cells from pluripotent cells and an understanding of how adult hepatocyte function is governed and can be manipulated by changes in heterochromatin states.